Cellular decoding of signaling dynamics

Signaling pathways are fundamental for the ability of cells to correctly respond to extracellular changes and
their dysregulation underlies variety of disorders and diseases, most notably cancer. Studies of central
signaling pathways revealed that cells encode information in the temporal dynamics of signaling and not just in
signaling amplitude. That is, signaling is not merely switched ON or OFF, but is tuned and adjusted to encode
meaningful temporal activity profiles (as oscillations, and pulses). This regulated tuning of the core pathway is
carried out by a numerous modulator protein that together form a regulatory network of feedback and control
loops. A long-standing challenge in cell biology has been to identify the proteins that can modulate temporal
profiles of central signaling pathways. Such identification is critical for elucidating cellular decision making in
health and its malfunction in disease. A central goal of my lab is to use the well-characterized Ras-Erk pathway
as model system to investigate the regulation of signaling dynamics and to uncover their involvement in cancer
disease. Multiple studies have substantiated the role of signaling dynamics in this pathway. Yet while much
progress was made in elucidating interactions in the core pathway, the understanding of how the surrounding
network regulates its dynamics and the role of this type of dysregulation in cancer is lagging far behind.
We and others, have recently started to unveil the importance of dysregulation of Ras-Erk dynamics by
showing that some oncogenic mutations alter the pathway’s signaling dynamics rather than amplitude.
However, while these findings provide a starting point, the high-throughput, systematic study of dysregulation
of dynamics remains highly underexplored because of the complexity of monitoring dynamics in live-cells and
incompatibility with current screening methods. My lab developed high-throughput microscopy and screening
approaches to overcome these technological limitations. We will leverage these platforms to investigate two
model in-vitro systems featuring variation in Ras-Erk dynamics: we will investigate the genetic (mutations)
mechanisms that underlie unlicensed proliferation (oncogenesis) and non-genetic (transcriptional and signaling
states) mechanisms underlying adaptive drug resistance against targeted-therapy. Successful identification of
mechanisms underlying Ras-Erk dynamics will both promote the understanding of a very central pathway
involved in development and disease and will uncover a new type of targets amenable for therapeutic
intervention. These include identifying new mutations driving oncogenesis and uncovering new proteins and
interactions that can be targeted to hinder disease progression and drug resistance. Moreover, this research
will impact the broad scientific community by demonstrating a strategy and methodology for resolving the
intricate connections between signaling dynamics and cell-fate decisions - a connection that emerges as
fundamental for many cell decisions and multiple disease.

Public health relevance
Healthy cells in the human body use temporal patterns of activity in signaling pathways to encode information about the extracellular environment. Many diseases, foremost cancer, stem from corruption of these temporal signaling patterns which culminate in maladaptive outcomes, as uncontrolled cell proliferation. We will study how intracellular dysfunctions, as mutations, corrupt information encoding and will investigate which cellular processes need to be targeted in order to restore proper encoding.